Pilot Project Program

Abstract
A major component of Phase III CoBRE funding for the Center for Cancer Biology Research (CCBR) is funding
of a Pilot Grant Program. The Pilot Grant Program's mission is to promote innovative and impactful cancer
research in the Midwest. The CCBR's on-going Pilot Grant Program has been tremendously successful in
funding projects that ultimately contributed to publications in peer-reviewed journals as well as grant funding
from the National Institutes of Health as well as foundations. A great majority of Pilot Grant awardees utilize the
CCBR's Scientific Cores. As these investigators obtain larger funding sources, they continue to rely on the
CCBR's Cores for generating needed data. Thus, the ultimate success of the Pilot Grant Program is a clear
investment in the CCBR and its Scientific Cores. Included within the Pilot Grant Program will be a Voucher
Program which will provide funds for Core usage. We expect this program to be highly successful as the CCBR's
Scientific Cores are well known in the region for their quality work and quick turnaround time. The Voucher
program will provide the ability for investigators to utilize the Scientific Cores, providing a means for obtaining
data that will ultimately contribute to publications and extramural funding. In these ways, the Pilot Grant program
will significantly contribute to the self-sustainability of the Scientific Cores. Moreover, many Pilot Grants stem
from collaborations between CCBR PIs and investigators from other centers or institutions. Thus, the Pilot Grant
Program will continue to expand the CCBR itself, as well.